Integrative analysis of genomics and proteomics to identify candidate molecular transducers of cardiorespiratory fitness

Project Summary/Abstract:
Cardiorespiratory fitness (CRF) is an integrative measure of cardiopulmonary and metabolic health, and a
powerful, independent predictor of future risk of mortality. No pharmacotherapies target CRF, and while
exercise training (ET) remains the only established means to improve fitness, substantial inter-individual
variability exists in both its intrinsic (untrained) level as well as its response to ET. Limited information exists
regarding CRF’s underlying biology and identifying its molecular underpinnings may help inform our
understanding of the determinants of this clinically important trait. Emerging data highlight circulating
biochemicals, and in particular proteins, as mediators of exercise’s health benefits (“exerkines”).
To better understand the molecular pathways involved in exercise and CRF, the NIH Common Fund created
MoTrPAC, the most comprehensive effort to study human exercise to date. MoTrPAC includes gold-standard
measures of CRF (VO2max), and deep molecular profiling - including whole genome sequencing (WGS) and
large-scale plasma proteomics. Moreover, the MoTrPAC study designs utilizes a randomized, controlled trial of
ET with a non-exercise control arm to allow for the identification of determinants of VO2max changes in
response to ET (VO2max). Though the generation of large multi-omics data in MoTrPAC presents enormous
opportunity, a major challenge remains in identifying the most promising biochemical determinants of CRF to
be brought forth for further, mechanistic studies. We and others have previously shown that integrating
genetics, proteomics, and functional genomics (e.g. tissue expression and knockout models) using statistical
colocalization can inform understanding about a protein’s regulation and suggest a causal role in health and
disease. These studies can, in effect, prioritize plasma proteins to be triaged for further investigation.
This proposal integrates plasma proteomics, WGS and VO2max traits from MoTrPAC with tissue expression
data from GTEx to prioritize candidate protein determinants of CRF. In Aim 1, we will apply a novel 5,000
assay plasma proteomics platform (Olink5K) in ~1,980 MoTrPAC participants undergoing ET to identify
circulating proteins related to baseline VO2max and VO2max leveraging the non-exercise control arm in
MoTrPAC. In Aim 2 we will: A) identify locally-acting (cis-) genetic instruments related to plasma proteins from
Aim 1 (cis-protein quantitative trait loci, pQTLs) from existing, publicly available datasets (TOPMed, UK
BioBank) as well as generate new cis-pQTLs using WGS from MoTrPAC; and B) gain functional insights into
the genetic regulation of VO2max-related proteins through colocalization with tissue expression in GTEx
(expression- or eQTLs). These experiments will help determine whether a plasma protein is regulated at the
transcriptional level and/or in tissues relevant to VO2max (e.g. heart, skeletal muscle) and set the stage for
further mechanistic studies that extend beyond the scope of this project.

Public health relevance
Project Narrative Cardiorespiratory fitness (CRF) is an integrative measure of cardiopulmonary and metabolic health and independent predictor of long-term survival that can be improved with exercise training. Despite this, limited knowledge exists regarding the biochemical pathways that underlie CRF. Our goal is to combine novel blood protein profiling technology with genetics and gene expression databases from Common Fund resources to identify promising candidate protein determinants of CRF – findings that set the stage for further mechanistic studies.